BLOOD GLUCOSE CHANGES ASSOCIATED WITH FEEDING IN HUMANS

Rodent studies have demonstrated that a transient decline (5-10%) in blood glucose precedes the initiation of feeding behavior. This protocol examines whether this phenomenon is present in human beings.